Core B: Biostatistics and Bioinformatics

Summary/Abstract
The Biostatistics and Bioinformatics Core (Core B) facility will provide study design, pipeline development, data
management, and computational support for all SPORE in Leukemia investigators and projects. The
Biostatistics component of the Core will perform consultation and collaboration on all aspects of statistical
study design, database development, quality control, data analysis and interpretation. The Bioinformatics
component of the Core will perform consultation and collaboration on all aspects of genomics and
bioinformatics study design, pipeline development, multi-omics data integration, visualization, interpretation
and genomic data sharing through controlled access systems. Core B will provide bioinformatics and
biostatistics collaborations for SPORE projects, Developmental Research Program (DRP) studies, and other
Cores to ensure that robust statistical methods and robust reproducible omics analyses are available to
support SPORE investigators. Core B will also provide bioinformatics and biostatistical support and training to
junior investigators through the Career Enhancement Program (CEP). The Biostatistics and Bioinformatics
components of Core B will work together closely to ensure their efforts are integrated and complementary.